Neurodevelopment in Urban Environments: Role of Exposure to Ambient Air Pollution

DESCRIPTION (provided by applicant): The growing population of children in American cities is exposed to various neurotoxins present in urban environments which may damage their developing brains. Over the last decade, environmental health scientists have generated compelling data on neurotoxicity in animals and humans exposed to present-day air pollutants from road traffic emissions (or traffic air pollution [TAP]), including particulate matter and ozon in urban environments. Experimental animal models have demonstrated that early life exposures to these urban air pollutants result in memory impairment and long-term neurobehavioral changes. Consistent with neurotoxicological literature, previous data from both cross-sectional and longitudinal epidemiologic studies showed a wide range of adverse neurocognitive effects (including low IQ) associated with TAP exposure in school-aged or younger children. However, it remains unclear whether TAP-mediated adverse neurocognitive effects persist into later life possibly affecting academic performance and educational attainment in adolescents and young adults. Although toxicologists have revealed clear evidence of air pollution-induced neurotoxicity in the prefrontal lobe and hippocampus, epidemiologic studies have not yet examined higher cortical control functions (e.g., executive functions [EFs]; emotion regulation) as neuropsychological mediators of the adverse exposure-effects on neurodevelopment. Previous studies only provided very little insight on the likelihood of joint adversities resulting from exposures to both neurotoxic TAP and social stressors commonly experienced by urban-dwelling children. To address these knowledge gaps, the primary objectives of this application are to: (1) generate preliminary data and infrastructure needed for a planned long-term study on neurodevelopment in urban environments; and (2) develop a conceptual framework to elucidate neuropsychological pathways contributing to impaired cognition and long-term socioeconomic consequences of exposures to urban air pollutants. Specifically, we propose a longitudinal study built on an ongoing (2000- onwards) and well-characterized urban-dwelling Southern California Twin Cohort (R01MH058354) with comprehensive data on neuropsychological functions and outcomes assessed from school-age (aged 9-10) to young adults (aged 19-23). This application leverages the unique, prospectively-collected environmental data and resources of the ongoing Children's Health Study, enabling the estimation of early life (1990-onward) exposure to air pollution and detailed characterization of intra-urban TAP exposure during adolescents. Drawing from two theoretical models (cognitive vulnerability-stress response and emotional dysregulation) in mental health research, we will test the hypothesis that EFs/emotion regulation and their developmental trajectories serve as both the central target and neuropsychological mediators of subsequent adverse effects of TAP exposure on cognitive abilities and socioeconomic attainment. The successful performance of this project may greatly advance the emerging field of developmental neurosciences in urban environments.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neurodevelopment in Urban Environments: Role of Exposure to Ambient Air Pollution Project Narrative Public Health Relevance: Children in American cities are frequently in contact with various toxins present in urban environments that potentially damage their developing brains, and this population of youngest and most sensitive citizens is still growing. Emerging scientific data in the past decade showed that air pollutants from roadway emissions, an important source in the urban environment, may affect the intellectual development in young children. Scientists at the University of Southern California assembled for this application are planning to move this new scientific field forward by studying a large group of children who are twins from urban communities of Southern California, one of the geographic areas with the most polluted air in the U.S. They will investigate whether the adverse effects of urban air pollution these children had encountered near the places they had lived and studied affect the development of higher cortical brain function resulting in poor cognitive ability (e.g., low IQ score) and limited attainment in education and other socioeconomic status as young adults. __SpecificAimsTextDelimiter__ 2. Specific Aims The long-term goal of this project is to better understand how urban environments, especially exposure to neurotoxic air pollutants during vulnerable time periods, contribute to neuropsychological development in adolescents and young adults. Urbanization is likely the single most important worldwide demographic shift during the past century. In 2010, near 45 million American children aged 18 or younger lived in metropolitan areas.11 Of the estimated over 4 million births in 2012, 28% will be in major cities. Although urban living may offer more employment opportunities for working adults, there are various physical and social environmental stressors that may adversely affect developmental processes and brain functions. In the last decade, environmental health scientists generated compelling data on neurotoxicity in animals and humans exposed to present-day air pollutants from road traffic emissions (or traffic air pollution [TAP]),12 including particulate matter (PM) and ozone in urban environments. Experimental animal models have shown prenatal and/or early life exposures to urban air pollution result in memory impairment and long-term changes in neurobehavioral performance.13-19 Consistent with growing evidence from neurotoxicological literature, both cross-sectional and longitudinal epidemiologic studies in school-aged or younger children have also found a wide range of adverse neurocognitive effects (including low IQ) associated with TAP exposure.20-27 More recent studies have further linked prenatal and early-life exposure to urban air pollution with increased risks for autism28, 29 and attention deficit and hyperactivity disorders.30 Although these intriguing data support the possibility that ubiquitous TAP exposure can perturb neurodevelopment of urban-dwelling children, there are several major limitations to previous epidemiologic studies. First, it remains unclear whether TAP-mediated adverse neurodevelopmental effects persist into later life affecting cognitive ability (e.g., IQ; academic performance) and educational/socioeconomic attainment in adolescents and young adults. Second, although toxicological studies have revealed clear evidence of air pollution neurotoxicity in the prefrontal lobe and hippocampus, 13, 14, 31-35 epidemiologists have not yet investigated higher cortical control functions (e.g., executive functions and emotion regulation) as mechanistic mediators for adverse effects of TAP exposure on neurodevelopment. Third, we have limited knowledge about joint adversities of exposures to both neurotoxic TAP and social stressors (e.g., in schools, homes, and other social contexts) and how they interact over time to influence neurocognitive outcomes, although importance of social-chemical interactions in environmental health risk has been increasingly recognized.10, 36-38 To address these knowledge gaps in a cost-efficient manner, we propose a longitudinal study built on an ongoing and well-characterized Southern California (SC) Twin Cohort (R01MH058354) with comprehensive data on neuropsychological functions and outcomes collected from school-age (aged 9-10 at the cohort inception) to emerging adults (aged 19-23 in 2011-2014). This project also leverages the prospectively- collected, unique environmental data sources across SC urban communities made available by the ongoing Children's Health Study,39-44 enabling the exposure estimation from the early life (1990-onward) and detailed physico-chemical characterization of intra-urban TAP exposure during adolescence (2003-2009). Drawing from two theoretical models (cognitive vulnerability-stress response45, 46 and emotional dysregulation47-49), the planned R01 seeks to clarify how urban air pollutants affect and interact with the putative neuropsychological pathways to shape the developmental trajectories of cognitive abilities in determining the subsequent educational/socioeconomic outcomes in adolescents and young adults. To this end, the specific aims of this exploratory R21 project are to: 1. Develop and validate spatiotemporal models and estimate the air pollution exposure data from gestation to adolescence for a longitudinal study of twins in urban environments 2. Generate the preliminary data for testing the three main hypotheses (H1-H3) of the future R01: H1: Exposures to urban air pollution during prenatal/early life and adolescence result in adverse cognitive outcomes (low IQ; poor academic performance) and limited educational/socioeconomic attainment in adults. H2: The neuropsychological mediators for long-term adverse neurocognitive outcomes involve developmental delay in executive functions and emotional dysregulation associated with urban air pollution exposure. H3: Urban air pollution exposure and social risk factors interact over time from gestation to adolescence to shape the neurodevelopmental trajectories/predict the educational/socioeconomic outcomes in later life. For this application, we have assembled a team of experienced researchers with expertise in behavioral sciences, neuropsychology, environmental health, air pollution epidemiology, and spatial statistics. The successful performance and expected results of this study will greatly advance the emerging field of developmental neurosciences in urban environments.